Effects of Maternal Genetic Risk Factors for Polycystic Ovary Syndrome on Birth and Childhood Outcomes in Offspring

PROJECT SUMMARY/ ABSTRACT
Polycystic ovary syndrome (PCOS) is a major health concern that affects up to 10% of reproductive-aged
women and incurs an estimated economic burden of $8 billion in annual healthcare costs in the U.S. This
complex, heterogenous condition is characterized by ovulatory dysfunction and hyperandrogenism and is
associated with increased risk for metabolic dysregulation. Not included in cost estimates are the impact on
offsprings of mothers with PCOS, who are at increased risk for adverse birth outcomes as well as the
metabolic and androgenic features of PCOS. Evidence from clinical studies suggest that maternal PCOS could
have causal biological effects in the intrauterine period that lead to adverse child outcomes; however, the role
of PCOS genetic factors in the development of these adverse child outcomes is not known. Distinguishing
between the contributing roles of the intrauterine environment and transmitted PCOS genetic factors to these
adverse offspring outcomes would directly impact the timing (peri- vs. postnatal) and population (mothers vs.
offspring) of targeted interventions to prevent PCOS and its associated comorbidities in children. The central
hypothesis for this proposal is that maternal PCOS genetics, by acting through pre- and perinatal factors, play
an integral role in the development of adverse birth outcomes and childhood metabolic and androgenic
phenotypes in offspring. To test this hypothesis, this project will take advantage of a recently completed
genome wide-association study meta-analysis that has doubled the number of genetic loci that influence
PCOS risk and the increasing availability of mother-offspring data in biobanks. This project leverages the
power of four pediatric cohorts, Avon Longitudinal Study of Parents and Children (N>6,000), Copenhagen
Studies on Asthma in Childhood (N>500), Project Viva (N>500), and the Growing Up Today Study (N>1,000).
In mothers and their offspring, PCOS genetic risk scores (i.e., estimated genetic susceptibility to PCOS) will be
calculated. The effect of maternal PCOS genetic risk on the relationship between perinatal factors and adverse
birth outcomes will be assessed, and the pre- and perinatal factors associated with maternal PCOS genetic
risk that influence metabolic and androgenic phenotypes in offspring will be defined. This proposal promises to
dissect the roles of transmitted PCOS genetic factors and the intrauterine environment in the development of
adverse birth and childhood outcomes, and thereby pave the way for a precision-medicine approach to care
that breaks the transgenerational cycle of PCOS and its related comorbidities.

Public health relevance
PROJECT NARRATIVE Polycystic ovary syndrome (PCOS) is a major health concern that affects up to 10% of all reproductive-aged women, and offspring of women with PCOS are at increased risk for adverse birth outcomes as well as the metabolic and androgenic features of PCOS. The goal of this study is to distinguish between the contributing roles of the intrauterine environment and transmitted PCOS genetic factors to these adverse offspring outcomes by leveraging recent advances in PCOS genetics and increasing availability of biobank data. The results of this proposal will directly impact the timing (peri- vs. postnatal) and population (mothers vs. offspring) of targeted interventions to prevent PCOS and its associated comorbidities in children, and thus, pave the way for a precision-medicine approach to care that breaks the transgenerational cycle of PCOS and its related comorbidities.